HMGA2 mediates resistance to therapy in prostate cancer

PROJECT SUMMARY
Epithelial-mesenchymal transition (EMT) is well characterized in epithelial cancers where tumor cells at the
invasive front lose epithelial markers such as E-cadherin, gain mesenchymal markers such as vimentin, to
promote invasion, migration and subsequent metastasis; it can be promoted by transcription factors such as
High Mobility Group A2 (HMGA2). Treatment for metastatic PCa is problematic, especially if it becomes
metastatic and castration-resistant (mCRPC). Current first-line hormone therapy for metastatic PCa includes
abiraterone that inhibits androgen biosynthesis, and enzalutamide that binds to androgen receptor (AR) and
prevents its translocation to the nucleus, while in less developed nations where these novel hormonal
therapies are not available, docetaxel is the main therapy. However, resistance to these drugs usually
develops and EMT has been shown to contribute to this resistance. Neuroendocrine advanced PCa has been
treated with Aurora A kinase inhibitor, alisertib/MLN8237, while combination treatment of MLN8237 with
abiraterone in mCRPC in 9 patients was terminated due to toxicity and lack of clinical benefit. Interestingly,
MLN8237 inhibits EMT in pancreatic and ovarian cancer cells. Overexpression of HMGA2 in pancreatic, lung
carcinomas and carcinoma of oral cavity, and prostate cancer is published where it promotes EMT, while we
reported that full-length but not truncated (missing 3’UTR) HMGA2 promotes EMT. Our preliminary data from
cBioportal in 444 metastatic PCa patients shows that 3% of the patients show HMGA2 amplification. 43% of
these metastasis patients with HMGA2 amplification received abiraterone treatment, while 21% received
enzalutamide and 36% received MLN8237. Interestingly, we further show that MLN8237 is able to inhibit cell
growth in LNCaP cells overexpressing both full-length/wild-type and truncated HMGA2 as well as LNCaP Neo
control cells. However, only wild-type HMGA2 confers resistance to docetaxel and enzalutamide concomitant
with increased AR expression and localization within the nucleus, compared to cells expressing truncated
HMGA2. The hypothesis is that wild-type HMGA2 confers resistance to docetaxel and hormone therapy
in metastatic PCa via AR-dependent and -independent mechanisms that may be overcome by
treatment with MLN8237, or pre-treatment with MLN8237 to first inhibit EMT followed by treatment with
hormone therapy. We will confirm resistance to docetaxel, enzalutamide and abiraterone in several AR-
dependent and AR-independent cell lines expressing HMGA2 by manipulating HMGA2 expression and
analyzing HMGA2 expression and localization in cells resistant to these drugs and elucidate the mechanisms.
We will also examine whether MLN8237 inhibits EMT in PCa and the effect of single and combination
treatments in vivo. Our studies will be impactful in showing that wild-type HMGA2 can be used as a biomarker
to avoid treatment with hormonal therapy and instead utilize MLN8237 or pre-treat with MLN8237 to inhibit
EMT followed by treatment with docetaxel or enzalutamide.

Public health relevance
PROJECT NARRATIVE Epithelial-mesenchymal transition (EMT) can mediate resistance to chemotherapy (docetaxel) and hormone therapy (enzalutamide) that is the current treatment options for metastatic and castration resistant prostate cancer (PCa), while an Aurora A kinase inhibitor (MLN8237) has been a treatment option being tested in clinical trials for neuroendocrine PCa. We will examine whether wild-type HMGA2 that promotes EMT, confers resistance to docetaxel and hormone therapy in metastatic PCa via AR-dependent and -independent mechanisms that may be overcome by treatment with MLN8237, or pre-treatment with MLN8237 to first inhibit EMT followed by treatment with hormone therapy. Our studies will be impactful in showing that wild-type HMGA2 can be used as a biomarker to avoid treatment with hormonal therapy and instead utilize MLN8237 or pre-treat with MLN8237 to inhibit EMT followed by treatment with docetaxel or enzalutamide.